Wisconsin Nathan Shock Center

Abstract Research Development Core
The Wisconsin Nathan Shock Center (WiNSC) will serve as a hub for highly collaborative and innovative aging
research and training, with a focus on metabolism and translation. The goal of the Research Development (RD)
Core is to support the expansion of top-level research in aging, to identify and support talented early-stage
investigators, and provide a means for established investigators to pivot towards new and innovative avenues of
aging research. The RD Core we will leverage existing expertise and infrastructure to attract greater investment
and commitment to aging research, build on our nationally competitive programs, and address the critical need
to translate biological insight to human health. Our program is designed specifically to enhance the pipeline for
development of new ideas, provide funding at critical stages in idea development, and provide intellectual and
mentoring support for early-stage investigators and those established investigators new to aging research.
To accomplish the goals of the RD Core, four distinct research support programs will be offered along
with a stage-specific mentoring structure and overall integration and implementation of the community-building
goals of the WiNSC. The RD will draw from a rich pool of investigators and trainees to expand aging research
locally and nationally including the NSC network and the aging research community at large. In conjunction with
the Administrative Core and the Executive Committee (EC) the RD Core will award yearly a minimum of 15
Research Awards among these distinct funding mechanisms: Pilot Awards, Idea Awards, Weindruch Scholars
and Mini-Sabbaticals. Pilot Awards function to support highly innovative approaches or new concepts, Idea
Awards are built to rapidly fill experimental gaps, Weindruch Scholars are up-and-coming early-stage
investigators, and Mini Sabbaticals support external scientific and networking development in partnership with
aging focused investigators nationally. The RD Core will provide mentoring and infrastructure to build a highly
integrated network of researchers and trainees in the basic biology of aging, focusing on the metabolic aspects
of aging and/or age-associated diseases, and non-clinical translational research applied to age-associated
diseases. To expand the impact of our research program and to enhance translation in aging research we will
co-sponsor (cost-matching) Pilot Awards from our colleagues at the UWCCC, ICTR, and ADRC, selecting from
their pool of pilot applications those that are aging relevant and thematically aligned with the mission of the
WiNSC. For each support mechanism the EC and RD will establish an appropriate Review Committee, and once
awarded will establish a mentoring plan and iterative guidance to reach research and career milestones.

Public health relevance
Project Narrative Not required per RFA-AG-25-012.